Elucidating the Mechanistic Details of the Grp94 Molecular Chaperone through an Integrated Computational and Experimental Approach

Project Summary/Abstract
Chaperone proteins are critical for cell survival and provide pathways for correct protein folding within the cell.
Our research focuses on ATP-dependent chaperones in the endoplasmic reticulum, specifically Grp94. Grp94
belongs to the highly conserved Hsp90 superfamily, and like its cytosolic and mitochondrial paralogs, it folds
and activates specific client proteins. Grp94 is of fundamental interest because it has limited mechanistic
information compared to other paralogs. Grp94 is also unique because it has several observed structural and
functional differences from paralogs that make it a promising drug target. Despite the importance of Grp94
chaperoning in protein homeostasis, the fundamental details of its chaperone cycle are not well characterized.
Grp94 is of practical interest since aberrant protein folding in the endoplasmic reticulum results in medical
issues such as type 2 diabetes, cancer, hepatitis B & C, and neurodegenerative and cardiovascular diseases.
Understanding Grp94’s structure and function will provide a foundation for understanding how diseases caused
by misfolded ER proteins can be treated and prevented. This fundamental knowledge of Grp94 mechanisms
can aid in rational drug design. Current strategies involve ATP-competitive inhibitors that target all Hsp90
paralogs and inhibit both productive and unproductive chaperone activity, which results in toxicity. Novel
therapeutic strategies include inhibiting chaperoning of toxic proteins while retaining chaperoning of non-toxic
proteins and targeting specific Hsp90 paralogs; however, mechanistic information is required to move the field
in this direction. Therefore, the studies of this chaperone mechanism will be of immense practical and
economical value in the development of disease therapies. Understanding the conformational changes
involved in the chaperone cycle is fundamentally important for identifying points of intervention. Understanding
how client proteins and other chaperones structurally and functionally interact is fundamentally important for
designing competitive modulators of Grp94.
My lab will develop novel techniques for functional and structural studies of Grp94. We will tightly couple
experimental and computational studies, which is a powerful combination of tools that will enable us to
elucidate molecular details that wouldn’t be possible to obtain with either method individually. Using this
approach, we will answer the following pertinent biological questions: (1) What are the preferred
conformational states of Grp94 and which conformations co-exist in equilibrium? (2) How do cellular conditions
and interactors influence Grp94’s conformational sampling? (3) What type of chaperone activity does Grp94
demonstrate and what are the requirements? (4) Where do client proteins interact on Grp94? (5) Are ATP
hydrolysis events in the Grp94 dimer symmetric or asymmetric? The successful completion of these studies is
expected to have an important impact in deconvoluting the Grp94 chaperone mechanism, the structural
changes involved, and the details of substrate protein interactions and processing. This information will
facilitate in finding new and novel points of intervention to ameliorate disease.

Public health relevance
The molecular chaperone Grp94 plays an important role in facilitating proper folding of proteins in the endoplasmic reticulum. Failure to maintain proper folding results in various disease states, making Grp94 an attractive therapeutic target. Successful completion of this work will significantly increase our understanding about the fundamental structure and function relationship involved in the Grp94 chaperone mechanism.